INHALED PENTAMIDINE FOR PNEUMOCYSTIS PNEUMONIA PROPHYLAXIS

This protocol studies the effectiveness of inhaled pentamidine for the prophylaxis of pneumocystis carinii pneumonia in patients with AIDS or ARC, and compares effectiveness of a uniform dose of inhaled pentamidine administered by two different nebulizer types.